Advancing patient-centered research using meta-analysis of individual patient data to identify clinically significant trajectories of PTSD/SUD and recovery outcomes

PROJECT SUMMARY/ABSTRACT
Substance use disorders (SUD) are globally prevalent and costly, and polysubstance use is more common
than single-substance use. The public health consequences of SUD are compounded by co-occurring
posttraumatic stress disorder (PTSD), with several associated outcomes linked to increased mortality, To date,
PTSD/SUD treatment evidence syntheses have been repeatedly criticized for “low quality” evidence due in part
to several methodological limitations: study-level predictors do not always mirror individual-level effects, study-
level measurement bias cannot be corrected in conventional meta-analytic methods, covariates are not always
appropriately managed, and few syntheses estimate comparative effect sizes for distinct PTSD/SUD treatment
approaches against common controls. Additionally, SUD and PTSD/SUD treatment outcome research has
historically emphasized reduction in substance use and clinical severity, not psychosocial recovery, despite the
importance of recovery-oriented outcomes to patients seeking treatment. The current project addresses these
limitations of the PTSD/SUD treatment literature by using meta-analysis of individual-patient data (MIPD)
combined with Integrative Data Analysis (IDA; to adjust for PTSD and SUD measurement error), propensity
score weighting (PSW; to mitigate against confounding that can result when “mixing and matching” treatment
arms across multiple trials), and contemporary approaches to quantifying clinically significant change (CSC;
instead of mean group differences) to test the comparative efficacy of pharmacological, behavioral, and
combination treatments for PTSD/SUD on clinical severity and psychosocial recovery outcomes.
Thus, in response to RFA-DA-22-037, we propose three Specific Aims. Aim 1: Conduct new analyses on
recovery-focused outcomes to evaluate comparative effects of behavioral, pharmacological, and combination
treatments for PTSD/SUD. Aim 2: Expand MIPD/IDA methodologies to individual-level statistical inferences
regarding the proportion of patients with clinically significant improvement/deterioration across treatment
classes. Aim 3: Update and extend MIPD comparative effectiveness analysis of PTSD severity, SUD/AUD
consumption, and recovery outcomes to an expanded 60-trial, 8000+ participant PH dataset.
The novel integration of CSC into a patient-centered MIPD will yield results that, instead of comparative
effectiveness of treatments on average, will give providers information on optimal patient/treatment matches—
through greater precision in the expected probabilities for meaningful improvement or deterioration on PTSD,
SUD, and recovery outcomes. If successful, this project will yield a synthesis of evidence in short order for the
impact of existing PTSD/SUD treatments on clinical and recovery outcomes.

Public health relevance
PROJECT NARRATIVE This project will use meta-analysis of individual patient outcomes, integrative data analysis, and propensity score weighting to test the comparative efficacy of pharmacological, behavioral, and combination treatments for individuals with co-occurring post-traumatic stress disorder and substance use disorder (PTSD/SUD). Findings will shed new light on how these treatments exert clinically significant change on PTSD symptom severity, substance use, and recovery outcomes. By applying advanced quantitative methodologies to individual patient data from over 60 randomized controlled trials, this project will yield a patient-centered synthesis of evidence in short order to inform optimal patient/treatment matches—and even guide providers about which treatments should likely be avoided for some patients with PTSD/SUD.